Virus breathing and assembly-disassembly transitions in host-entry

Project Summary
Viruses are serious human pathogens and viral infectious diseases represent a continuing challenge for global
human health. The long-term focus of my research program is to uncover host-induced changes in pathogenic
human viral dynamics by targeting the first critical steps of virus entry into human host cells. Our specific focus
is icosahedral human viruses, that are made up of small individual constituent protein monomers compiled into
repeat triangle units to generate a spherical virus assembly. The defining feature of these icosahedral virus
particles is metastability or the ability to be reversibly assembled or disassembled, in response to the shifting
environmental conditions encountered as part of its lifecycle. This ability to transition between assembled and
disassembled states arises from viruses in solution being ‘spring-loaded’ high energy states that are continuously
undergoing reversible fluctuations, referred to as ‘breathing’. These intrinsic dynamics of all viral particles allow
environmental sensing, facilitate receptor recognition while evading detection by the immune system.
Consequently, when a virus encounters an unsuspecting host cell, it binds the receptor, undergoes endocytosis
and undergoes a program of viral disassembly to release its genome inside the host cell. These intrinsic
dynamics of the viral particle further allow the virus particle to traverse multiple host-specific environments, evade
host immune systems, to propagate viral replication and complete the viral lifecycle. An understanding of
dynamics is critical for a deeper understanding of the precise mechanisms of how viruses enter human host
cells. The study of dynamics of virus-host cellular entry has lagged structure determination. Structures of
numerous-antibody complexes by cryo-EM offer powerful insights into how these viral particles appear in
‘snapshots’. However, they do not directly provide information into the inherent ‘breathing’ of viral particles in
solution, nor do they delineate the dynamic mechanisms by which these viruses undergo conformational
changes upon encounter of, and entry within, human host cells. Our research program will unravel dynamics of
host entry in several classes of pathogenic icosahedral viruses- enveloped RNA viruses- flaviviruses (dengue,
zika), non-enveloped RNA viruses (Coxsackie viruses) and non-enveloped DNA virus (Human Papilloma virus).
This will be achieved through integration of cryo-EM with dynamics mediated by structural mass spectrometry
and biophysical and RNA chemistry probes. The goals of our research program on viral particle dynamics, host
entry and genome egress will advance therapeutic antibody and small molecule discovery for improving human
health outcomes against viral diseases.

Public health relevance
Project Title: Virus breathing and assembly–disassembly transitions in host entry Project Narrative The critical first steps in an infectious virus’ lifecycle which include receptor recognition and disassembly upon contact, are poorly understood. Our proposed research program will determine the steps for how intact virus particles precisely disassemble upon interactions with host cell receptors, to release the viral genome inside the human host cell. This will be achieved by monitoring virus dynamics in multiple icosahedral model viruses through integrative structural mass spectrometry, cryo-electron microscopy, biophysical and RNA chemistry approaches.